Emory Vaccine and Treatment Evaluation Unit - DMID 21-0004

Summary/Abstract The Emory VTEU has proven essential in the fight against the pandemic. This supplement will allow for further investigations into vaccines trials during pregnancy or postpartum. 1

Public health relevance
Narrative The Emory VTEU will participate in DMID 21-0004 (Maternal NI) an Observational, Prospective Cohort Study of the Immunogenicity and Safety of SARS-CoV-2 Vaccines Administered during Pregnancy or Postpartum and Evaluation of Antibody Transfer and Durability in Infants. 1